Modulating the adaptive immune response to enhance the efficiency of in vivo gene editing in muscle

Project Summary
Duchenne muscular dystrophy (DMD) is a debilitating and incurable muscle wasting disease caused by
inherited mutations in the Dmd gene, which encodes the muscle structural protein Dystrophin. Therapeutic
approaches that seek to cure DMD must include a strategy to repair or replace the mutant Dystrophin protein.
A recent series of papers from my lab and others demonstrated the potential feasibility of using adeno-
associated virus (AAV) mediated delivery of CRISPR-Cas9 nucleases to make site specific DNA cleavages in
the Dmd gene within skeletal muscle fibers, cardiomyoctyes and muscle stem cells of living animals. We have
shown that this in vivo gene editing strategy is sufficient to restore Dmd reading frame and enable production
of functional Dystrophin protein that can increase muscle specific force and protect DMD muscle from
contraction-mediated damage. This strategy presents some advantages with respect to other “exon skipping”
approaches, in that it allows efficient recovery of Dystrophin protein in both the skeletal muscle and heart, and,
because it effectively targets muscle stem cells and irreversibly modifies the Dmd locus, it offers potentially
permanent restoration of Dystrophin expression in dystrophic tissues.
Yet, despite its promise, there remain significant potential challenges for clinical application of in vivo gene
editing. In particular, the bacterially-derived Cas9 nuclease represents a potential antigenic target for the host
immune response. In fact, our preliminary data indicate that Cas9 is rapidly and robustly recognized by the
immune system when ectopically expressed in the muscle of immune competent mice. In addition, analyses of
human sera indicate that more than half of potential human recipients of Cas9 therapies harbor pre-existing
antibody and T cell responses to Cas9 orthologs due to prior infection with the bacteria from which these
proteins derive. Thus, induced or pre-existing anti-Cas9 immune responses may lower the efficiency of
therapeutic gene editing in muscle by causing the immune-mediated elimination of Cas9 transduced, gene-
edited cells. Moreover, emerging data indicating that the immune system and its products can modulate the
expression of AAV-encoded transgenes and of components of cellular DNA damage response pathways raise
the possibility that anti-Cas9 immunity could alter both the degree of on-target Dmd editing as well as the
frequency and types of off-target modifications induced.
In this project, we will test the hypotheses that robust anti-Cas9 responses reduce the production and
durability of gene-edited cells and alter the frequency of potentially genotoxic edits, whereas opposing Cas9
immunity through genetic or pharmacologic manipulation will increase the efficiency, safety and durability of
Dystrophin recovery by gene editing. This work will establish whether the anti-Cas9 immune response helps or
hinders in vivo gene editing and will be critically important for the design of future clinical efforts using this
approach.

Public health relevance
Project Narrative Programmable genome modification using the CRISPR-Cas9 gene editing system has enormous therapeutic potential for rescuing gene function in individuals bearing mutations that cause inherited diseases like Duchenne Muscular Dystrophy (DMD); yet, introduction of bacterial Cas9 protein into mammals can trigger an immune response, which may pose a barrier to the use of this system for human gene therapy. This project will investigate how the immune response to Cas9 affects gene editing in a mouse model of DMD, by assaying differences in the relative rates of therapeutic gene modifications, as well as potentially deleterious mutations, in mice with intact or disrupted immune systems. Results from this work will aid evaluation of the efficiency, durability and safety of in vivo gene editing for DMD, and inform the design of future clinical approaches that utilize CRISPR-Cas9.